Adhesome signaling in lung injury and repair

PROJECT SUMMARY
Idiopathic pulmonary fibrosis (IPF) is a progressive and fatal fibrotic lung disease. IPF is
characterized by fibroblast and myofibroblast foci and excessive accumulation of
extracellular matrix (ECM) proteins. IPF is prevalent among the Veteran population.
Myofibroblast differentiation is thought as one of the responsible mechanisms for
excessive ECM protein production and accumulation, leading to progressive fibrotic
lesions in lung. It is important to understand the molecular mechanisms that are
responsible for myofibroblast activation in IPF. Tristetraprolin (TTP) is a major regulator of
gene expression and modulates mRNA stability. The preliminary data demonstrate that
TTP function is impaired in IPF. We speculate that impaired TTP function likely results in
a dysregulated regulation system of gene expression, and consequently leads to
pathological conditions. This proposal aims to investigate the role of TTP as a break to
limit fibrotic response and lung fibrosis. It is important to understand the molecular
mechanism leading to increased pro-fibrotic response in IPF. The preliminary data
demonstrate that TTP regulates ECM protein expression and signaling that are important
for myofibroblast differentiation and functions, and gain of TTP decreases ECM protein
expression and signaling, and myofibroblast differentiation in IPF lung fibroblasts. We
hypothesize that impaired TTP fosters a ‘pro-fibrotic ECM niche’, fueling cell-matrix
interaction and signaling that increases myofibroblast differentiation and fibrotic
responses. This proposal aims to define the role of TTP in myofibroblast differentiation
and lung fibrosis, examine the molecular mechanism involved, determine the impact of
impaired TTP function on ECM production and accumulation, and the role of TTP in
fibrogenesis and fibrotic remodeling in vivo. Completion of this project will provide new
insight about the mechanisms responsible for the development of pulmonary fibrosis and
serve the goal to develop more effective therapy for IPF patients.

Public health relevance
PROJECT NARRATIVE There is a need to understand the molecular mechanisms responsible for pro-fibrotic responses in idiopathic pulmonary fibrosis. Cell matrix interaction plays a fundamental role in normal and diseased conditions. This proposal is to understand the critical mechanisms that leads to deadly pulmonary fibrosis.